Aerobic Exercise for Optimizing Cognitive and Brain Health In Remitted Late-Life Depression

ABSTRACT
Late-life depression (LLD) increases risk for numerous poor health outcomes in aging, including medical
multi-morbidities, disability, and mortality. Importantly, LLD also doubles the risk for dementia relative to the
general aging population. Impairment in select cognitive domains (i.e., executive function) persists even after
remission of depressive symptoms in LLD. Lifestyle modification is currently the most promising non-
pharmacological approach for attenuating cognitive decline in aging and preventing dementia, yet has not been
used to target cognitive impairment in remitted LLD (rLLD). Aerobic exercise (AE) is a lifestyle factor that
enhances cognitive functioning, with pronounced benefits for executive functioning. AE also influences
neuroimaging markers of brain health in regions and networks critical for executive and memory function (i.e.,
prefrontal cortex, hippocampus, default-mode network). Critically, AE targets cognitive domains and brain
regions and networks showing the greatest and most persistent abnormalities in LLD.
The goal of the proposed study is to conduct a methodologically rigorous AE trial using comprehensive
neuroimaging and neuropsychological approaches to assess the potential of AE training to 1) target systemic
brain abnormalities and 2) cognitive deficits; and 3) to explore the extent to which AE effects on neuroimaging
markers of brain health relate to its cognitive benefits in those with rLLD. In accordance with the NIMH
Experimental Therapeutics approach, this project proposes a 6-month randomized controlled trial comparing
moderate-intensity AE to a social engagement (SE) comparison condition, to examine the extent to which AE
training influences structural and functional systemic brain abnormalities observed in those with rLLD. The
secondary study aim is to examine the direct effect of AE training on cognitive function in those with rLLD. I will
also explore the relationship between AE-related brain changes and cognitive improvements to probe neural
mechanisms of AE effects on cognition in those with rLLD. The training provided through this award will include
1) building expertise in conducting laboratory- and home-based explanatory exercise interventions in geriatric
psychiatric populations; and learning 2) advanced 7T neuroimaging data analytic methods and 3) longitudinal
statistical analytic methods.
In summary, this K23 study is the first step toward exploring biological mechanisms of the cognitive
remediating effects of AE in those with rLLD using an experimental therapeutics approach. The results of this
study will provide the necessary preliminary data to support the PI in her efforts to become an independent
clinical translational investigator in geriatric behavioral health.

Public health relevance
Project Narrative: Cognitive impairment and brain abnormalities are common and persist after depression remission in those with LLD, compounding dementia risk in both individuals with acute and remitted LLD. In this K23 application, we will examine systemic neural and cognitive benefits of aerobic exercise training in older adults with remitted LLD. This will generate preliminary data regarding neural targets of aerobic exercise training that may translate to cognitive benefits in those with rLLD, a population who remains at high risk for dementia despite successful treatment of depression.